Modeling Drug Induced Liver Injury with Patient-Derived Liver Organoids and Microfluidic Chips

Project Summary/Abstract
Drug-induced liver injury (DILI) is a significant concern due to its potentially life-threatening consequences and
its contribution to clinical trial failures and market withdrawals. Current models cannot accurately predict DILI
risk, necessitating the development of more physiologically relevant systems. We have previously
demonstrated the utility of patient-derived induced pluripotent stem cells (iPSCs) to produce human liver
organoids (HLOs) in a high-throughput, high-content microscopy-based screening for DILI. However,
optimizations are needed to enhance assay robustness and specificity mainly by ensuring that the HLOs
assayed are of high quality. We aim to optimize the assay system by implementing multiple quality control
measures throughout the differentiation process of HLOs. These measures include increasing the passage
number of iPSCs, confirming pluripotency marker expression, and validating lineage-specific markers at
various stages of differentiation. Additionally, we will utilize a comprehensive set of dyes to characterize
cellular populations within HLOs and gain insights into the mechanisms of DILI. We will screen a set of control
compounds known to cause DILI using our improved assay system and employ single-cell analysis techniques
to confirm known phenotypes. Furthermore, we will develop machine learning models to predict DILI
phenotypes based on cellular features, facilitating the identification of potential hepatotoxic compounds. This
approach will enhance our understanding of DILI mechanisms and enable the prediction of DILI risk in pre-
clinical drug development. Herbal dietary supplements (HDS) represent a significant but poorly understood
cause of DILI, with high variability in composition and limited regulation. The complexity of HDS-induced liver
injury (HILI) presents challenges for modeling and requires robust systems to elucidate underlying
mechanisms. I aim to predict HILI and identify specific molecules responsible for liver injury in HDS by utilizing
our established HLO assay system to screen a diverse collection of 23 HDS extracts obtained from patients
who have experienced HILI and 25 isolated natural products from these extracts for hepatotoxicity risk. Mass
spectral molecular networking will be employed to characterize the molecular composition of HDS extracts and
identify potential hepatotoxic compounds. Subsequent screening of purified compounds will confirm their
hepatotoxic effects, allowing us to characterize the mechanisms of HILI through transcriptomic analysis. This
approach will enable the identification of intrinsic hepatotoxicants and provide insights into the complex
mechanism of HILI. By combining high-content microscopy techniques with comprehensive molecular analysis,
we aim to improve our understanding of HILI and facilitate the development of predictive models for HILI.
Overall, DILI and HILI present a significant unmet medical need, and I plan to use HLOs and high-content
imaging to develop a superior pre-clinical model to predict HILI risk in HDS.

Public health relevance
Project Narrative Utilizing Human Liver Organoids (HLOs) to model Drug-Induced Liver Injury (DILI) provides a more physiologically relevant approach than traditional methods, enhancing patient safety in drug trials and enablaing a shift away from reliance on animal models. This advancement aligns with the objectives of the FDA Modernization Act 2.0, promising success in pre-clinical drug safety studies. Herein, we will leverage existing DILI patient-derived HLOs to screen and characterize the effects of herbal dietary supplements toward an improved method for liver injury risk prediction.